Dissecting the mechanisms through which Wnt5 signaling influences hematopoiesis

Project Summary/Abstract:
During blood cell differentiation (hematopoiesis), a precise balance must be achieved between
hematopoietic stem and progenitor cell (HSPC) maintenance, self-renewal, and differentiation. If
this balance is not properly achieved, hematological diseases such as leukemia can result.
There is mounting evidence that Wnt signaling plays an important role in regulating this balance
during normal hematopoietic development, and dysregulation of Wnt signaling is implicated in
leukemias and other hematologic diseases. Therefore, it is important to understand how Wnt
signaling is regulated during hematopoiesis to achieve a balance between HSPC maintenance
and differentiation. Wnt signaling can occur through canonical or non-canonical pathways, and
the role of the latter mechanism(s) in hematopoiesis is not well understood. The proposed
research program uses the Drosophila melanogaster blood system as a model system to
address unresolved questions how non-canonical Wnt5-mediated Wnt signaling affects
hematopoiesis. We recently discovered mechanisms by which canonical Wnt signaling and a
non-canonical Wnt6-mediated pathway act in specific subsets of HSPCs to control HSPC
maintenance, cell division, growth, and differentiation. We also see evidence that Wnt5
signaling plays a role in HSPC maintenance and differentiation during hematopoiesis. This
proposal consists of two Aims that will elucidate the molecular mechanisms involved in Wnt5-
mediated signaling during hematopoiesis and dissect how Wnt5 signaling integrates with other
signaling pathways involved in hematopoietic development such as the canonical Wnt pathway.
In Aim 1 we will dissect the signaling pathways downstream of Wnt5 in order to identify the
receptors and signaling intermediates required for Wnt5 to exert its effects on hematopoiesis.
We will also dissect the relationship between signaling components downstream of Wnt5 and
identify potential transcriptional targets of Wnt5 signaling. In Aim 2 we will identify which cells
produce and respond to Wnt5 and pinpoint when in development this signaling occurs.
Uncovering the molecular mechanisms required for homeostatic control of Wnt signaling during
hematopoiesis will provide valuable insights into mechanisms that cause aberrant Wnt signaling
in hematological diseases.

Public health relevance
Project Narrative To prevent blood diseases or blood cancers such as leukemia, our bodies must precisely control the number of blood cells that are generated from a pool of stem and progenitor cells (SPCs). One way this balance is achieved is through complex networks of cell-cell communication pathways. Our goal is to uncover the mechanisms by which several cell-cell communication pathways precisely control the balance between blood SPCs and mature blood cells to prevent blood diseases such as leukemia.